Four-dimensional multi-modality microimaging-microdevice system for high throughput drug screening in vivo

Project Summary
Guigen Liu, Ph.D., is a mechanical and optical engineer whose overarching career goal is to develop and
translate optical fiber based biomedical optical imaging and sensing technologies. The research, entitled “Four-
dimensional multi-modality microimaging-microdevice system for high throughput drug screening in vivo”,
combines the advanced optical microimaging system with an emerging microdevice, which has the huge
potential impact on drug development, individualized health care, and fundamental biomedical research.
Candidate: Dr. Liu is an Instructor at the Radiology Department of Brigham and Women’s Hospital, Harvard
Medical School. During his previous postdoctoral training, he and colleagues pioneered a silicon-tipped fiber-
optic sensing platform featuring high speed and high resolution, which earned the 2015 Alan Berman Research
Publication Award from the U.S. Naval Research Laboratory. While Dr. Liu has shown a successful track of
record in engineering, his training in biomedical research is limited. Through the career development plans: 1)
Gain more experience in two-photon fluorescence and Raman microimaging; 2) Learn to design and implement
the microimaging-microdevice system; 3) Establish in vivo drug delivery and tissue response testing skills; and
4) Enhance leadership and career development skills, Dr. Liu will launch his independent career in the new field.
Mentors/Environment: Dr. Liu has assembled a strong team of mentors to guide him through the proposed
training and research activities. The proposed career development plan includes the rich resources available
through Brigham & Women’s Hospital and Harvard Medical School, the Tearney Laboratory at the Wellman
Center for Photomedicine, and the Laser Biomedical Research Center at Massachusetts Institute of Technology.
Research: The research seeks to build an in situ multi-modality optical histological laboratory for the biomedical
microdevice, through four specific research aims: 1) To implement quantitative 4D multi-color two-photon
fluorescence microimaging; 2) To test drug efficacy in vivo using the 4D two-photon fluorescence MI-MD system;
3) To develop label-free MI-MD system using Raman microscopy; and 4) To investigate microimaging through
long and flexible GRIN probes. Completion of these aims will push the microdevice a big step toward potential
clinical adoptions in the future.
Summary: Innovation of the proposed research is the integration of 3D microimaging and microdevice for 4D
testing of drug efficacy and tissue response in vivo, which will meet the pressing needs of high throughput drug
screening. The candidate has identified a group of experts who provide complementary training and mentoring
on all the aspects for him to complete the proposed research and develop an independent research career.

Public health relevance
Project Narrative The standard-of-care way in clinical oncology to evaluate the drug response of a tumor is through in vitro and ex vivo protocols done on cells or tissues excised from the live tumor, which is incapable of investigating many important and often critical events that only occur in vivo. The proposed multi-modality microimaging-microdevice (MI-MD) system provides such a technology for high throughput testing of drug response in vivo, without the need to excise any tissues from the native tumor. The MI-MD system to be developed in this project will have high potential impacts on drug development, individualized health care, and fundamental biomedical research.